Comparative Pathology Shared Resource

Comparative Pathology Shared Resource Summary
The mission of the Comparative Pathology Shared Resource (CPSR) is to provide comprehensive pathology
support for Masonic Cancer Center (MCC) members who use laboratory animals in their research. The CPSR
is a critical resource for projects using animal tissues and is essential for publications involving pathological
changes in tissues. The CPSR operation has been led by M. Gerard O'Sullivan, MVB, PhD, since 2009 and is
supported by Technical Coordinator Katalin Kovacs, PhD; histotechnologist Paula Overn, HT, QIHC; and
postdoctoral research pathologist, Flaviu Tabaran DVM, PhD. Dr. O'Sullivan has more than 25 years of
experience in comparative and experimental veterinary pathology. The laboratory prepares appropriately
processed fixed or frozen tissues for histology and immunohistochemistry (IHC). Particular strengths of the
laboratory are in doing non-routine, challenging, or tedious histological preparations; performing IHC
preparations on multiple markers; developing new IHC protocols for markers of interest; and performing IHC on
bone. Board-certified veterinary pathologists provide expert gross and histopathologic analysis, generate high-
resolution digital images of specimens, and provide intellectual input on study design and manuscript
preparation for research projects and grant applications. The CPSR also has considerable experience in
developing new protocols and techniques and has developed 121 new IHC markers since 2012. In addition,
the CSPR has developed double-labeling techniques to simultaneously detect several combinations of
proteins. Requests for quantification of marker expression and histomorphometric evaluations have increased,
and CSPR has developed expertise to accommodate these requests. Weekly staff meetings and annual
feedback from CPSR users ensure that the resource is able to meet the needs of MCC members.